Project 2

ABSTRACT/SUMMARY:
Genetics lies at the core of hereditary spastic paraplegia (HSP). Despite the identification of more than 80
causative genes - half of which were discovered through the efforts of SP-CERN consortium members -
approximately 40% of HSP patients have yet to identify their causative gene. This gap impedes clinical studies,
biomarker research, and the progression of future clinical trials. The SP-CERN - RDCRC will prioritize
establishing a robust genetic foundation by systematically collecting blood, DNA, and RNA samples and
generating advanced long-read genomic data as part of the core protocol.
Dr. Stephan Zuchner, the Principal Investigator of Project 2 and Administrative Director of the SP-CERN at the
University of Miami, has been a leading figure in HSP genetics for over 15 years. His team and collaborators
have long been dedicated to the systematic aggregation of de-identified DNA samples and genomic data for
broad sharing and collaborative gene and allele discovery studies in HSP and related disorders. Recently, human
genomic studies have begun to expand significantly into the complex non-coding genome space - regions that
have been challenging to analyze using short-read sequencing. High-quality long-read genome sequencing will
accelerate new discoveries in this area.
In Clinical Research Project 2, we are building on our recent successes in identifying important new disease loci
for HSP-related diseases, as published in Nature Genetics (three times) and the New England Journal of
Medicine. We anticipate additional breakthroughs in HSP genomics in the coming years. Our expertise includes
software and bioinformatic tool development, access to a uniquely large long-read genome control cohort, and
data from 2,288 exomes and short-read genomes from HSP patients, as well as approximately 7,000
exomes/genomes from related disorders.
This SP-CERN - RDCRC Clinical Research Project 2 will closely collaborate with the SP-CERN Cores, training
and career enhancement initiatives, and the other Clinical Research Projects. We will support the genetic needs
of all SP-CERN investigators and serve as a bridge to other HSP genomics efforts worldwide (e.g., TreatHSP in
Europe). This Project proposes an integrated set of genomics approaches to further elucidate HSP genetics and
improve the quality of diagnostic efforts. Given the development of gene-targeting therapies for
neurodegenerative diseases like HSP, there is a renewed urgency in uncovering the complete genetic basis of
HSP.